NIMH INFORMATION SUPPORT CENTER

This contract will establish information support services (ISS) to provide the necessary services, facilities, and qualified personnel to screen and respond appropriately to inquiries addressed directly to the NIMH, or inquiries about mental health and mental illnesses that are referred to the NIMH from other Government offices for reply. The offeror with consultation and assistance from IRIB, will ensure that vitally needed and appropriate information on the diagnosis, prevention, treatment, and underlying causes of mental disorders is disseminated in a cost-effective manner, to members of the public and to the mental health and health care professionals responsible for their care.